The pathophysiological function of PNPLA3-148M variant in alcohol-induced liver injury

Project Summary
Alcohol-related liver disease (ALD) is a very common health problem among alcohol drinkers. Multiple
genome-wide association studies have reproducibly identified a single nucleotide polymorphism (rs738409,
C→G) in the human patatin-like phospholipase domain containing 3 (PNPLA3) gene, which results in isoleucine
(I) to methionine (M) substitution at amino acid 148, as the most significant gene variant associated with a broad
spectrum of ALD ranging from steatosis, hepatitis, to cirrhosis to date. PNPLA3 is a lipid droplet-associated
protein that is most abundantly expressed in human liver, which has been shown to have triglyceride lipase and
retinyl palmitate hydrolase activities. However, the pathophysiology of the 148M variant of PNPLA3 in the liver
remains largely unclear. In this project, we have developed transgenic mouse models for both variants of human
PNPLA3 and validated the key features of human ALD in the 148M mouse model. We aim to further address the
molecular underpinning of the 148M mutation in the alcohol-induced hepatic inflammation and fibrosis using both
cell and animal models. It is expected that the mechanistic investigation in this application will provide direct
evidence of the causal relationship between the 148M variant and the associated liver pathology. Altogether, we
believe that this project is highly significant and innovative.

Public health relevance
Project Narrative The proposed research in this application is highly relevant to public health because better understanding of the molecular pathogenesis of alcohol-related liver disease is expected to provide potential novel drug targets for the prevention and treatment of this common liver disorder. Specifically, the proposed research in this application will address the underpinning for the strong association of the human PNPLA3 gene with the alcohol-related liver disease. Thus, this project is highly relevant to the part of NIH’s mission that pertains to pursuing fundamental knowledge that will help extend healthy life and reduce the burdens of illness.